Regulation of gene expression by alternative polyadenylation

Abstract/Summary
Most mammalian genes harbor multiple cleavage and polyadenylation sites, or PASs, across the gene body,
resulting in mRNA isoforms with different coding sequences (CDS) and/or 3’ untranslated regions (3’UTRs).
Alternative cleavage and polyadenylation (APA) is an important layer of gene regulation, affecting gene
expression levels, protein diversity, and mRNA metabolism. The APA isoform expression varies across cell
types and is dynamically regulated in a growing number of cell conditions, such as cell proliferation and
differentiation, change of metabolic states, and cellular stress. Our lab employs interdisciplinary approaches to
study APA, involving molecular biology, functional genomics, and computational biology. Our long-term goal is
to understand the functional genomics of APA across species as well as molecular mechanisms and cellular
consequences of gene regulation by APA in different cell contexts and pathological conditions. In the next five
years, we plan to address a few key gaps in the field: First, we plan to examine regulatory rules governing
intronic polyadenylation that leads to early termination of transcription. Second, we will examine the role of
3’UTR isoform regulation in cell metabolic reprogramming, such as growth and autophagy. Third, we will
investigate the mechanisms and consequences of the unique APA isoform profile in secretory cells.

Public health relevance
Narrative: Most mammalian genes express alternative cleavage and polyadenylation (APA) isoforms with different coding sequences (CDS) and/or 3’ untranslated regions (3’UTRs). Our research goal is to elucidate molecular mechanisms of APA regulation and cellular consequences of APA isoform expression under various physiological and pathological conditions.